SIGNAL TRANSDUCTION MECHANISMS OF ERYTHROPOIETIN

The long term goal of this project is to understand the signal transduction mechanisms through which growth factors control hematopoietic proliferation and differentiation. This knowledge is essential to understand disorders of hematopoietic regulation including aplastic anemia and leukemia. The major goal of this grant is to understand the mechanisms through which erythropoietin (Epo) regulates ion channels during erythroid differentiation and to determine the functional role of calcium influx in erythropoiesis. This system is a model to delineate the immediate signaling events which follow interaction of Epo with its receptor on normal cells. The following specific aims will be addressed: Specific Aim 1: Identification of the signaling mechanisms through which Epo regulates calcium channels. We have characterized the Epo-modulated calcium channel with patch-clamp methodology and have determined that tyrosine phosphorylation and the G protein subunit Gialpha2 are required. We have also shown that Jak2 is involved. (A) Here, we will determine the Epo signaling pathways which link Jak2 to calcium channel activation. Involvement of STAT, Ras, or the IRS-2/PI 3-kinase pathways will be examined using microinjection of single BFU-E derived erythroblasts and quantitative fluorescence microscopy coupled digital video imaging. If Ras is required, the role of other transducers in the Ras pathway will be examined. (B) We will determine the domains of erythropoietin receptor required for Epo modulation of calcium channel opening. Specific Aim 2: Determination of the role of [Cai] in regulation of transcription factor activation in erythropoiesis. The functions of the NF-kappaB and bHLH transcription factors and the c-Jun N-terminal kinases (JNK) are modulated by calcium. We will determine if the amplitude or duration of the Ca++ response in erythroid cells affects NF-kappaB transcription factor activation, or if calcium/calmodulin levels influence DNA binding of bHLH proteins, particularly SCL. We will also determine the effect of [Cai] on JNK activation and the role of PI 3-kinase in this pathway.